Chemical Biology Strategies to Resolve Plasmodium Heat Shock Protein Function

Project Summary
Despite modern efforts to eradicate malaria, the disease continues to threaten the lives of over half the world's
population. The urgency to uncover novel drug targets in the blood and liver stages of Plasmodium parasites,
the causative agents of malaria, is exacerbated by strains resistant to frontline antimalarials. To address this
need, a better understanding of pathogen biology is imperative, particularly relating to essential, druggable
proteins. The Plasmodium falciparum heat shock proteins 90 and 70-1 (PfHsp90 and PfHsp70-1) are molecular
chaperones critical to multiple stages of the parasite's lifecycle. These proteins have N-terminal nucleotide
binding domains (NBD) that hydrolyze ATP and C-terminal domains that are critical for protein binding and
functional dimer formation. We previously identified several molecules that bind to the PfHsp90 NBD that potently
inhibit Plasmodium, but the role of the C-terminus for protein function has not been fully explored. We also
discovered that the PfHsp70-1 C-terminus has a critical role in lipid signaling under heat stress, but we lacked
chemical probes to resolve the function of the NBD in this process. Thus, we need domain-specific small
molecule probes to unravel the role of these protein domains in Plasmodium proteostasis and signaling. Our
goal is to understand mechanisms that support Plasmodium protein homeostasis and signaling by investigating
domain-specific PfHsp90 and PfHsp70-1 functions and to uncover their interactomes. In Aim 1, we plan to
develop domain-specific chemical probes that target PfHsp90 and PfHsp70-1. Candidates discovered through
target-based screening will be assessed for their affinity with biochemical methods and the ligand binding site
will be established with the mass spectrometry approach stability of proteins from rates of oxidation (SPROX).
Our preliminary efforts to date have yielded putative novel N-terminal and C-terminal binders for both chaperones
that we will optimize and employ in biological studies. In Aim 2, we will investigate the PfHsp90 and PfHsp70-1
interactomes using our chemical probes and genetic tools, respectively, in thermal proteome profiling and limited
proteolysis strategies. Prioritized chaperone interactors will be validated with biochemical methods. In Aim 3, we
will leverage our PfHsp90 and PfHsp70-1 chemical probes to link chaperone domains to the transcriptional stress
response, global protein regulation, and digestive vacuole stability in parasites. We will use RNA-sequencing to
assess the transcriptome and develop bioorthogonal noncanonical amino acid tagging (BONCAn to label and
track nascent proteins in Plasmodium after chemical probe addition. Digestive vacuole stabilization assays will
be completed after chaperone inhibition using live-cell microscopy. Together, this work will identify and
characterize parasitic molecular networks involving PfHsp90 and PfHsp70-1 to gain insight into their biological
function. Our chemical biology approach offers a route to complete fundamental biological studies throughout
different stages of the Plasmodium lifecycle and lays a foundation to disrupt pathways in drug resistant parasites
to address malaria.

Public health relevance
Project Narrative Malaria is a life-threatening disease that is caused by infection from Plasmodium parasites. Resolving pathways critical to both the liver and blood stages of Plasmodium infection, such as ones that involve heat shock proteins, is critical to aid in malaria control. This project will investigate the role of heat shock proteins 90 and 70 in Plasmodium infection to advance knowledge of essential parasite processes and aid in the pursuit of novel therapeutic strategies.